CONSULTING PROFESSIONAL SUPPORT SERVICES FOR SEER PROGRAM CLINICAL DOCUMENTS AND IMAGES (CDI) ACQUISITION ENHANCEMENTS

CONSULTING PROFESSIONAL SUPPORT SERVICES FOR SEER PROGRAM CLINICAL DOCUMENTS AND IMAGES (CDI) ACQUISITION ENHANCEMENTS-moonshot support